Exposure to metabolism disrupting chemicals: implications for maternal health in pregnancy

PROJECT SUMMARY
Support from this award will provide Maria Cinzori with comprehensive training in environmental epidemiology
and clinically-relevant perinatal health research, while providing additional guidance for conducting research
using a large national cohort (the Environmental influences on Child Health Outcomes (ECHO) consortium) and
applying causal inference-based statistical approaches under the supervision of an exceptional mentoring team
with expertise in environmental epidemiology, conducting perinatal health research (including in clinical settings),
and confronting the challenges and rewards of working with a large, harmonized dataset. Overall, the proposed
research will offer insights into associations between metabolism disrupting chemical (MDC) exposures and
maternal metabolic disorders in pregnancy. Pregnant women are exposed to numerous non-persistent (e.g.,
phthalates, phenols) MDCs through food packaging, personal care products, and household cleaning items.
Some limited studies suggest that certain single MDCs are linked to gestational diabetes and hypertensive
disorders of pregnancy – conditions that may increase maternal and child risk of developing type II diabetes or
obesity. Therefore, MDCs may be potential modifiable risk factors that can be targeted to prevent gestational
and cardiovascular complications. However, prior studies addressing this issue have been limited, focusing
primarily on non-clinical metabolic outcomes and single chemical classes in homogenous populations. Specific
Aim 1 of the current study will address this critical gap by evaluating associations of maternal exposure to
many classes of MDCs with gestational diabetes and hypertensive disorders of pregnancy. Completion of the
research in Specific Aim 1 will leverage data from ECHO, a diverse national cohort, to provide vital information
on how MDCs impact gestational metabolic health. Despite efforts to ban harmful chemicals, pregnant women
are ubiquitously exposed to emerging chemicals of concern via continuous introduction of unregulated
replacements. Although prior intervention studies evaluating phenols and phthalates suggest that there are
plausible individual-level approaches for reducing exposure to chemicals, it is time-consuming to test whether
implementing large-scale intervention is effective at improving health outcomes. To address these shortcomings,
Specific Aim 2 will apply novel causal inference-based statistical methods to evaluate how a hypothetical
intervention to decrease exposure to chemicals of concern would impact risk of developing gestational diabetes
or hypertensive disorders of pregnancy in pregnant women enrolled in ECHO. Furthermore, it is critical to identify
sources of emerging MDCs to inform future interventions, and therefore an exploratory aim will extensively review
the literature to identify targetable sources of novel and emerging MDCs with the goal of informing sustainable
policy-relevant interventions. The research accomplished in Specific Aim 2 will provide valuable information
about whether reducing MDC exposure can lower the incidence of gestational diabetes and hypertensive
disorders of pregnancy.

Public health relevance
NARRATIVE Pregnancy is a dynamic period with implications for women’s and children’s health. The proposed studies will fill a research and public health demand by providing timely information about the roles of metabolism disrupting chemicals in gestational diabetes and hypertensive disorders of pregnancy in mothers and identify the effect of reducing chemical exposure. Findings from this study will inform future policy development, research, and clinical practice on the modifiable risk factors contributing to metabolic and cardiovascular complications during pregnancy and the benefit of reducing chemical exposure during this sensitive window.